The Development and Psychometric Evaluation of the SIRS: A Social Isolation Risk Scale for Survivors of Head and Neck Cancer

Head and neck cancer (HNC) survivors have unique survivorship challenges (e.g., facial disfigurement), which
often lead to social isolation. To address social isolation and prevent associated negative health outcomes, it is
critical to identify HNC survivors at risk for social isolation. Currently, these efforts are hampered by a lack of
screening tools that are both sufficiently brief to be used routinely in a fast-paced clinic and capture the risk
factors unique to HNC that potentiate social isolation. Hence, the overall purpose of this proposal is to
develop and conduct a preliminary psychometric evaluation of the Social Isolation Risk Scale (SIRS), a
brief screening tool to identify HNC survivors at risk for social isolation. Aim 1: Develop the SIRS: Item pool
generation (1a): Our team will use inductive and deductive methods to generate a pool of potential scale
items (i.e., reasons why HNC survivors socially isolate, general social isolation risk factors) through
discussions among HNC survivor members of our advisory board, and experts in HNC, social isolation, and
measurement, as well as a literature review. Item pool refinement (1b): We will refine the item pool through
1-on-1 interviews with N = 30 socially isolated HNC survivors. We will solicit feedback on item relevance
(quantitative scale 1 to 5, higher values indicate more relevance), addition/deletion of items (items will be
added/deleted if 70% of those asked endorse addition/deletion), and suggestions for alternative wording via
qualitative feedback. At the conclusion of 1b, we will have a ~16-item SIRS (~8 items related to non-physical
social isolation risk factors and ~8 items related to physical social isolation risk factors), to undergo preliminary
psychometric evaluation during Aim 2b. Aim 2: Administer (2a) and conduct preliminary psychometric
evaluation (2b) of the SIRS. 2a. We will conduct a 3-month longitudinal study, in which we will administer the
SIRS, a demographic survey, and a battery of validated assessments of social isolation, general distress,
loneliness, social connectedness, social desirability, and HNC-related quality of life, to N=130 HNC survivors at
their 6-month (T1) and 9-month (T2) post-treatment completion visits. 2b. We will perform preliminary
psychometric analyses of the SIRS, evaluating both items’ properties and SIRS’ properties, as well as perform
a factor analysis. Based on a priori established guidelines, we will select a final set of items to retain for the
SIRS, with the goal of ~10 items in total (~5 items related to physical risk factors and ~5 items related to non-
physical risk factors). This project is (a) significant, as it will improve the long-term health of a substantial (at
least 36%) subset of HNC survivors and will serve as a model for identifying and preventing social isolation in
other at-risk groups; and (b) innovative, as it approaches the problem from a different perspective- focusing on
the root cause (i.e., social isolation) of negative outcomes, rather than the negative outcomes themselves.

Public health relevance
Head and neck cancer (HNC) survivors, due to their unique illness- and treatment-related effects and symptoms, are at risk for social isolation (the objective lack of contact with other people), a demonstrated precursor to poor physical and mental health outcomes. The goal of this study is to develop (through item generation and refinement) and conduct a preliminary psychometric evaluation of the SIRS (Social Isolation Risk Scale), a brief screening tool that will allow clinicians to routinely identify HNC survivors at risk for social isolation, and simultaneously capture the specific risk factors unique to HNC (e.g., facial disfigurement, trouble speaking) that potentiate social isolation. Identifying HNC survivors at risk for social isolation using the SIRS, and administering targeted, evidence-based prevention strategies is critical to preventing the development of social isolation in the short-term, and negative health outcomes in the long-term.